High throughput electrosynthesis for enhanced drug discovery via light-powered smart microelectronics

Abstract
OWiC Technologies' Fast Track project aims to introduce an innovative, user-friendly platform for high-
throughput electrosynthesis to accelerate the discovery of novel small-molecule drugs. Traditional synthetic
methods used in drug discovery are limited in the scope of reactions they can promote and the types of bioactive
compounds they can prepare. Moreover, many complex medicinal agents require resource-intensive, multi-step
synthesis with hazardous chemicals, making them economically and environmentally inefficient. In recent years,
electrosynthesis has gained recognition as an enabling synthetic technology with the potential to substantially
enhance researchers' ability to access novel compounds and accelerate drug discovery efforts. However, its
adoption in the pharmaceutical industry remains limited due to the complexity of existing reactors and the
specialized expertise required to operate them. Additionally, these setups are incompatible with high-throughput
synthesis and screening. To address these challenges, OWiC Technologies will develop Smart Photoelectronics
for Electrochemical Synthesis (SPECS)—a cutting-edge technology designed to enable nonspecialists in
medicinal chemistry to seamlessly adopt electrochemical reactions in their R&D efforts. SPECS are miniature
microelectronic chips that can be easily integrated into commercial 96- and 384-well plates containing microliter
volumes of reactant solutions. These devices use small silicon photodiodes to generate electric currents upon
visible light exposure, powering on-chip electrodes to drive electrosynthesis in a wireless fashion and eliminating
the need for traditional wired equipment. This breakthrough will enable high throughput electrosynthesis with
unparalleled efficiency and flexibility, allowing researchers to control redox reactions through precisely
programmed current or voltage inputs. Since SPECS can seamlessly integrate into existing workflows for high-
throughput experimentation, drug developers can effortlessly adopt electrosynthesis for rapid preparation of new
compound libraries, streamlining drug discovery. OWiC has received positive feedback from potential customers,
highlighting the technology’s potential to dramatically improve the scalability and user-friendliness of
electrochemistry, while enabling the creation of previously unattainable drug molecules. Specific Phase I
objectives include: 1) Developing SPECS with voltage and current control, 2) Integrating systems to record and
report reaction conditions, and 3) Demonstrating the synthesis of known compounds using SPECS-enabled
electrochemistry. Phase II goals focus on: 1) Scaling the technology for high-throughput screening with
enhanced consistency and robustness, 2) Developing software for direct output control, 3) Incorporating diverse
electrode materials to expand reactivity and selectivity, and 4) Piloting SPECS in academic research laboratories
for validation and further improvement. By the project's conclusion, OWiC Technologies expects to
commercialize SPECS as a transformative tool for drug discovery.

Public health relevance
Narrative The development of disruptive synthetic technologies to rapidly access drug molecules is a pressing priority in today’s pharmaceutical industry. Researchers face increasing challenges in creating new treatments, leaving millions of patients reliant on suboptimal medications or without effective options. OWiC Technologies’ innovative solution provides drug developers with new synthetic tools to expand compound libraries with molecules previously unattainable through conventional methods, accelerating drug discovery to address unmet medical needs in conditions such as heart disease, cancer, and diabetes.